Resistance Mechanisms in ROS1-Fusion-Driven Malignancies

Project Summary
Gene fusions of the orphan receptor tyrosine kinase, ROS1, are expressed in a range of malignancies. My lab
and other labs have demonstrated that ROS1 gene fusions drive neoplastic transformation of cells in vitro and
are tumorigenic in vivo when concurrent with loss of tumor suppressor (TP53). It is thought that these gene
fusions transform cells via uncontrolled ROS1 kinase activity. Importantly, clinical implementation of the first-
generation ALK and ROS1 tyrosine kinase inhibitor (TKI), crizotinib, has resulted in significant reduction of
tumor burden in patients with ROS1-fusion positive tumors. However, the efficacy of crizotinib treatment is
often short-lived as resistance to the drug emerges after a period of time. Therefore, ongoing research efforts
will be required to discover second-line or combination therapeutic options.
Clinical resistance to crizotinib treatment has taken on two forms: 1) aberrations in alternate signaling
pathways that compensate for any loss in ROS1 kinase signaling (“bypass pathway aberrations”) and 2) loss of
TKI potency due to point mutations in the ROS1 kinase domain. While both forms of resistance are equivalent
in terms of incidence, little attention has been provided towards understanding bypass pathway aberrations.
Notably, a patient that our collaborators at Memorial Sloan Kettering Cancer Center (MSKCC) are treating has
stopped responding to crizotinib therapy for ROS1-fusion positive non-small-cell lung cancer after initially
seeing tumor regression. Sequencing of the crizotinib-resistant tumor found a copy-number amplification
(CNA) in the transcription factor, MYC, that was absent in the initial tumor. I hypothesize that CNA of MYC
represents a bypass pathway aberration that has reduced the efficacy of crizotinib treatment in this patient and
that this phenomenon can occur in other tumors. To study this, I will 1) reversibly perturb MYC in cells derived
from the patient tumor to determine if ROS1-TKI sensitivity is restored and 2) overexpress MYC in a crizotinib-
sensitive, ROS1-fusion expressing human broncho-epithelial cell line to observe if ROS1-TKI resistance
appears.
Unlike bypass pathway aberrations, much research has been conducted to characterize ALK and ROS1 kinase
point mutations that confer resistance to crizotinib. This has aided the design of second-generation ALK/ROS1-
TKIs like lorlatinib that can bind to the ROS1 kinase domain even in the presence of these mutations. However,
I hypothesize that resistant point mutations will develop towards the new TKIs and that predicting them will
inform future drug design. To study this, I will perform a forward mutagenesis screen in a lorlatinib-sensitive
ROS1-fusion cell line to identify mutations in ROS1 that confer resistance to lorlatinib.
Taken together, achieving the objectives of this project will: 1) discover a bypass pathway aberration that
causes resistance to the ALK/ROS1-TKI, crizotinib, and 2) identify ROS1 point mutations that confer resistance
to a next-generation ROS1-TKI, lorlatinib. This will help combat future ROS1-TKI resistance in patients.

Public health relevance
Project Narrative Gene fusions of the receptor tyrosine kinase, ROS1, have been shown to drive neoplastic transformation of cells in a range of malignancies and targeted therapy with tyrosine kinase inhibitors (TKI) that have activity against ROS1 kinase domain, has led to significant reduction of tumor burden in patients. Unfortunately, clinical resistance to TKI therapy frequently occurs, which limits its long-term durability as an anti-tumor treatment strategy. This project will explore a novel mechanism by which resistance to ROS1-TKI emerges from an alternate signaling pathway and predict new resistant point mutations in ROS1 that confer resistance to the next generation of ROS1-TKI therapy.